Characterizing the microbial and inflammatory state within distant clinically healthy tissues in patients with active periodontal disease

Project Summary/Abstract
Periodontitis is one of the most chronic oral inflammatory disease in humans and affects more than 10% of the
global population, while gingivitis is estimated to affect more than 46% of all adults aged 30 years or older in the
United States alone1, 2. While advances in periodontal research over the past 50 years in both humans and
animal models has vastly improved our understanding of the etiology and pathophysiology across the spectrum
of this disease3-11, most studies have focused on investigating the severe, chronic, and irreversible form of
periodontal disease, periodontitis, often in comparison to other healthy individuals. Critical knowledge gaps
remain in our understanding of how inflammation is triggered and maintained during the reversible, intermediary,
and most prevalent form of periodontal disease – gingivitis1, 2, 12, 13, and importantly what cell types, functions,
and signaling is disrupted leading to further chronic inflammation progression and ultimately periodontitis.
To date, several single cell transcriptome (scRNA-seq) studies aimed at resolving active cell types within
gingival tissues in health and disease (experimental gingivitis, periodontitis) have been published. However, at
the time of this application, no scRNA-seq studies characterizing gingivitis have been published or made
available to the broader scientific community – representing a significant knowledge gap. Furthermore, no
existing scRNA-seq datasets have aimed to resolve the relationship of active periodontal disease associated
bacteria within subgingival plaque to observed active cell expression in adjacent gingival tissues. In this study
we seek to employ recent advances in scRNA-seq14 to increase cell recovery and capture underrepresented cell
types in current periodontal scRNA-seq datasets (gingivitis and periodontitis), while robustly characterizing the
dental plaque microbiota and target chemokines/cytokines in GCF in parallel. This will uniquely allow us to
resolve key differential signaling pathways between healthy sites and gingivitis and between gingivitis and
periodontitis. In particular, the activity of key cell types (neutrophils, macrophage, mast, natural killer,
conventional dendritic, and various T-cells) involved in the activation of enzymatic degradation of periodontal
tissues and osteoclast differentiation effecting alveolar bone resorption during periodontitis. Overall, a major
thrust of NIH/NIDCR in general is to provide single cell resolution of active inflammatory cell types across tissues.
The success of this project and deposition of resulting data will significantly contribute to existing public
resources15, 16 and greatly expand current knowledge. Resolving transcriptionally active cell types within gingival
tissues, soluble host immunomodulatory signals, and the active bacteria within sites of active inflammation
compared to distant clinically healthy tooth sites in the same individual may identify key signaling pathways and
regulatory mechanisms for future therapeutic, diagnostic, and mechanistic studies that aim to maintain healthy
homeostasis, resolve periodontal inflammation, and prevent periodontal disease progression.

Public health relevance
Project Narrative Investigating active immune cells at the single cell level in relation to active bacteria, their genetic components, and community composition, in subgingival dental plaque during varying stages of periodontal health and disease, including gingivitis and periodontitis, may provide mechanistic insight in how the reversible state of gingivitis becomes dysregulated resulting in the irreversible state of periodontitis. Applying new single cell techniques can aid in resolving the activity of underrepresented cells in tissues and help elucidate specific signaling pathways used by these cells in health and disease and provide information that can be used in future diagnosis and therapeutic strategies.